Molecular mechanisms underlying morphogenesis of the tectorial membrane

PROJECT SUMMARY/ABSTRACT
The tectorial membrane (TM) is an extracellular matrix (ECM) that lies over the organ of Corti. The TM plays
important roles in frequency selection, propagation, and amplification of sound waves. Malformation of the TM
causes hereditary hearing deficits. Since the TM is an acellular structure, its unique properties arise from the
matrix architecture. The TM exhibits sophisticated ultrastructural features and domain-specific patterns of
matrix organization. However, the mechanisms by which the specific matrix architectures are organized
outside of cells are unknown. Is it determined by its molecular composition and/or mode of organization? We
observed that surface-tethering of a-tectorin/TECTA via a glycosylphosphatidylinositol (GPI)-anchor is required
to prevent diffusion of secreted TM components into the luminal space of the scala media and to form the TM
matrix on the apical surface of TM-producing cells. The release of TECTA plays a critical role in the growth of
the TM layers. Our in vitro assays show that TECTA is released from the producing cells by multiple
mechanisms and that the different forms of TECTA released by these distinct mechanisms show unique
multimerization activities. In this proposal, we will determine the molecular mechanism by which TECTA
mediates the organization of specific TM architecture. We will characterize molecular dynamics that occur
during the matrix maturation. Our results will provide the first evidence of how a complex ECM structure is
established and matures in the extracellular space at the molecular level. This will provide novel insights into
the process of morphogenesis as well as the mechanism of hereditary and age-related hearing deficits.

Public health relevance
PROJECT NARRATIVE The tectorial membrane (TM) plays important roles in frequency tuning and amplification of sound waves. The TM displays sophisticated ultrastructure and domain-specific organization of matrix architecture. By understanding how the specific matrix structure of the TM matrix is organized, our research has the potential to provide novel insights into the morphogenesis process and the physiological functions of the TM in normal and disease conditions.